CORE 4- Small Animal Core

SUMMARY-SMALL ANIMAL CORE
A critical component of our vaccine development program is efficacy testing of candidate antigens in murine
models of C. difficile infection. The Small Animal Core of our program will achieve this goal and identify lead
antigens for the development of novel vaccines to prevent against CDI. The Small Animal Core will be led by Dr.
Eric Skaar. The Skaar laboratory has significant experience in the murine model of C. difficile infection and has
also developed a new live C. difficile vaccine model in mice as described in Project 2. In addition, the Skaar
laboratory has experience testing the therapeutic efficacy of both small molecules and antibodies in murine
models. This experience will be used to guide the creation of a Small Animal Core to test the efficacy of lead
antigens developed by this program. The Small Animal Core will benefit from the expertise of the Translational
Pathology Shared Resource (TPSR) which includes access to a board-certified veterinary pathologist with
experience in in vivo modeling of human disease, including molecular pathology, toxicopathologic assessment,
and digital pathology as well as advanced training in veterinary anatomic pathology and murine models. The
Small Animal Core will receive optimized candidate antigens from Scientific Core 2. These proteins will be tested
for efficacy in appropriate murine models of CDI. Candidate antigens will be tested alone or in combination.
Combined, the efforts of the Small Animal Core will result in the identification of lead antigens for the development
of novel vaccines that protect against infections caused by C. difficile.